The University of Miami AIDS Research Center on Mental Health and HIV/AIDS - Center for HIV & Research in Mental Health (CHARM)Research Core & MHD-CE

PROJECT SUMMARY: MENTAL HEALTH DISPARITIES AND COMMUNITY ENGAGEMENT CORE (D)
The Mental Health Disparities and Community Engagement (MHD-CE) Core in the Center for HIV and
Research in Mental Health (CHARM) provides specific services and activities to promote research to
understand, assess, and intervene with sociocultural and structural drivers at the intersection of HIV and
mental health disparities. Racial, ethnic, sexual, and gender minority populations are the least likely to benefit
from medical advances in HIV prevention and treatment, and the most susceptible to comorbid HIV-related
mental health (MH) problems (including substance use), affecting all aspects of the HIV prevention and care
continua. CHARM is located in a US HIV/AIDS epicenter and home to one of the largest populations of racial,
ethnic, and sexual/gender minority individuals placed at risk for and living with HIV/AIDS in the nation. The
environment includes multiple risks and disadvantages that set the stage for disparities in access to and
utilization of HIV and MH services and in HIV/AIDS and MH outcomes. Thus, the MHD-CE Core strives for
meaningful local impact as well as nationally contributions in order to end the HIV epidemic.
The MHD-CE Core will further expand on our highly successful set of activities as a Developmental ARC
such as bringing the expertise of community members to the forefront to directly inform research priorities;
sponsoring the “Charming Conversations” Series; partnering with the Dev Core to support a community pilot
grant mechanism to fund pilot grants spearheaded by a community-based organization; implementing two
consent-to-contact databases (PLWH and community members); and equipping researchers with the tools and
expertise to conduct ethical, equitable, and high impact research with marginalized communities.
As a Full Center, CHARM’s MHD-CE Core will continue to promote rigorous, multilevel, culturally competent
research addressing mental health (MH) struggles faced by communities most impacted by the HIV epidemic
due to racism, heterosexism, cisgenderism, and ethnocentrism. This will be accomplished by providing expert
consultation from a multidisciplinary team of investigators and clinicians in psychology, public health,
psychiatry, education, and medicine with expertise in HIV and mental health inequities and a broad range of
MH disorders common to PLWH or at risk for HIV; facilitating and maximizing the impact of community-
engaged and responsive mental health and HIV research through bi-directional collaboration of UM
investigators with community stakeholders; engaging potential research participants from hard-to-reach
populations placed at risk for HIV; informing content and providing access to measures of multi-level and multi-
domain constructs relevant to HIV and MH inequities; and hosting a Speakers series. The MHD-CE Core will
therefore promote innovative and theory-driven research approaches, stimulating research in synchrony with
CHARM’s mission of reducing the impact of mental health and minority health disparities across the HIV
prevention and care continua.

Public health relevance
Project Narrative for Other Components Please see Overall Component for Project Narrative. PAR-20-308 Guidelines Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components. SF424 Guidelines Overall Component: The "Project Narrative" attachment is required. Other Components: Refer to the specific FOA to determine whether the "Project Narrative" attachment is required for any Other Components. Note: The form may show ‘*’ indicating it is a required field, but it is only required for the Overall Component and the ‘*’ can be ignored for Other Components.